Elucidating Neuron-Intrinsic Molecular Mechanisms of Optic Nerve Regeneration

PROJECT SUMMARY
To understand the neuronal intrinsic control of optic nerve regeneration, we initially conducted an extensive
molecular dissection of the PTEN/PI3K/AKT/mTOR complexes signaling network, illuminated their cross-
regulating mechanisms, and definitively determined the linear and parallel signals that contribute to optic nerve
(ON) regeneration. We then developed a novel Retro-seq platform to label, purify, and single cell sequence
regenerating and non-regenerating retinal ganglion cells (RGCs), by which we identified a group of downstream
effectors of PTEN deletion that directly promote significant ON regeneration and surprisingly, also produce
striking glaucoma neuroprotection. We propose the common target of these pro-regeneration and pro-
neuroprotection genes may be the mechanistic nodal point that drives axon regeneration and neuroprotection
directly. We will investigate another top gene from the regeneration-associated gene list and its functional related
molecules to illustrate the potential new mechanisms of neuronal intrinsic control in adult CNS axon regeneration.
Moreover, we will test individual pro-regeneration genes and their combinations in our newly developed acute
and chronic mouse SOHU glaucoma models, in hope of identifying the most effective neural repair strategies
that promote significant neuroprotection and visual functional recovery. These in-depth focused studies of
prominent pro-regeneration and neuroprotection genes and their interactions are likely to illustrate a novel
mechanism of axon regeneration, identify the most promising therapeutic targets, and therefore eventually
establish translational strategies for safe and effective clinical management of glaucoma and other CNS
neurodegeneration patients.

Public health relevance
PROJECT NARRATIVE Neural repair treatment including axon regeneration and neuroprotection is urgently needed for glaucoma and other optic neuropathies, the leading cause of irreversible blindness. The proposed experiments are built on solid previous results and promising preliminary data to advance our understanding of the molecular mechanisms of optic nerve regeneration and glaucoma neuroprotection. The experiments have the potential to lead to innovative pro-regeneration and pro-neuroprotection treatments to fulfill this urgent, significant unmet clinical need.